THERAPEUTIC OLIGONUCLEOTIDE PLATFORM BIOLOGICS CHEMISTRY, MANUFACTURING AND CONTROLS (CMC), SUBJECT MATTER EXPERT CONSULTING SERVICES.

The National Institutes of Health (NIH) is seeking a highly experienced, senior-level, biological
therapeutics development consultant with expertise in Therapeutic Oligonucleotide Platform
Biologics Chemistry, Manufacturing and Controls (CMC). This individual would be expected to
provide guidance and advice on biologics development processes for the National Institute of
Neurological Disorders and Stroke (NINDS) Ultra-Rare Gene Therapy (URGenT) program, the
NIH Blueprint Neurotherapeutics (BPN) Biologics program, and other NINDS and trans-NIH
programs where therapeutic oligonucleotide CMC expertise is required.